10th International Unstable Microsatellites and Human Disease Meeting

Project Summary
This application requests funding for the 10th International Microsatellites and Human Disease (UMHD10)
conference to be held in Guanacaste, Costa Rica from January 14th to 19th, 2025. The UMHD conference
series has successful track record of scientific exchange and clinical collaborations that have encouraged
breakthrough research. Since their discovery in the early 1990s, research into repeat expansion mutations
have led to novel insights into fundamental biological processes, which has produced significant therapeutic
progress. Microsatellite repeat expansions are associated for 70+ human diseases, ranging from common
neurological disorders, like Alzheimer’s disease (AD), Amyotrophic Lateral Sclerosis (ALS), and autism
spectrum disorder (ASD), to rarer disease, like Huntington’s Disease, Myotonic Dystrophy, and
spinocerebellar ataxias (SCAs). UMHD10 finds the field sitting on a cusp of transformative change across
multiple fronts, but also facing significant barriers. While repetitive sequences have been estimated to
make up 75% of the human genome, research into the role of these sequences in biological processes is still
ongoing. On the clinical front, the complexity and variability associated with many repeat expansion
disorders has limited therapeutic progress. UMHD10 aims to attract the brightest minds in the field with a
comprehensive program that provides an inclusive and open environment for the open exchange of ideas,
the creation of interdisciplinary collaborative peer networks, and the development of career skills. The three
main specific aims/objectives of the meeting are (1) to advance the field’s understanding of the role of
microsatellites in human biology and to spur development of therapeutic technologies, analytics, and tools
to tackle associated human diseases; (2) to provide an inclusive and open environment for the exchange of
ideas, the creation of interdisciplinary collaborative peer networks, and the development of career skills;
and (3) to increase participation in the microsatellite field at all stages (research, clinical & advocacy) by
individuals typically underrepresented in biomedical research. The meeting’s goal is to advance
understanding of microsatellites in human biology and to spur development of therapeutic technologies,
analytics and tools to tackle the associated human diseases.

Public health relevance
Project Narrative The 10th International Microsatellites and Human Disease (UMHD10) conference to be held in Guanacaste, Costa Rica from January 14th to 19th, 2025 aims to attract the brightest minds in the field with a comprehensive program that provides an inclusive and open environment for the open exchange of ideas, the creation of interdisciplinary collaborative peer networks, and the development of career skills. The meeting’s goal is to advance understanding of microsatellites in human biology and to spur development of therapeutic technologies, analytics, and tools to tackle the associated human diseases. The UMHD conference series has successful track record of scientific exchange and clinical collaborations that have encouraged breakthrough research.